The relationship between fMRI and patient-reported outcomes in chemotherapy-induced neuropathy: A diversity supplement

Summary of Parent Grant (R01CA245054)
Chemotherapy induced neuropathy (CIN) is a severe side effect that impacts greater than 60%
of cancer patients. CIN impacts treatment duration and dosing, functional mobility, and quality of
life. This proposal examines the effect of auricular point acupressure (APA) as an innovated
solution for CIN. APA utilizes a non-invasive, active modality of treatment stimulating points on
ear to improve CIN symptoms. Utilizing a mobile application on smartphones, this project
teaches participants how to stimulate their ears for three minutes, 3 times a day to alleviate
pain. Given limited understanding of the mechanism of pain relief, participants will complete
multiple questionnaires: Quantitative Sensory Test, Revised Brief Pain Inventory-CIN, PROMIS-
29, Opioid Use, Experience and Attitude, and Demographic data. Additionally, imaging studies
and biomarkers will be obtained. Functional MRI (fMRIs) will obtain pre-, post-, and follow-up
APA evoked signal changes and pro- and anti- inflammatory cytokines will be collected. The
goal of this study is to ascertain the efficacy of APA as a self-managed, adjunctive therapy to
enhance CIN management, through understanding the underlying mechanisms of APA on CIN.

Public health relevance
Project Narrative This diversity supplement secures clinical scientist mentors who will support the development of Dr. Nguyen towards becoming an independent clinician-researcher. Dr. Nguyen will gain experience to clinical trial design, recruitment, participant retention, data management and analysis, manuscript and proposal development. As a junior faculty, this supplement will provide needed resources and scientific training to establish a foundation for Dr. Nguyen to start a research career focused on nonpharmacological therapies, patient-reported outcomes and quality of life among individuals with brain injuries.